Annual Health Economics Conference Grant

Title: 28th Annual Health Economics Conferences Abstract: The Department of Health Policy and Management at the Emory University Rollins School of Public Health seeks funding to support continuation of the highly successful Annual Health Economics Conferences (AHEC) for 2017 to be held at the University of Southern California. The AHEC uses a small conference format for rigorous presentation and discussion of health economics research, with special attention to its application to policy. In this context, the aims of these conferences are: (1) to advance the policy applicability of health economics by exploring theoretical issues with high potential for application to real-world health settings; (2) to improve the policy relevance of empirical health economics by fostering research that emphasizes the study of important current policy questions using rigorous methods; and (3) to develop the next generation of health economic scholars by placing promising junior economists with high-profile senior economists in an intensive 1.5-day, small group setting. Over the past 24 years, AHEC has been hosted by most of the major universities that offer advanced degree programs and have major funded research programs in health economics and health services research. The unique nature of each conference focus combined with the prestige of each university has ensured exceptionally high quality papers and serious interactions among conference participants. This conference will build upon past success by (1) retaining the core structure and tradition of AHEC, with extensive discussion of leading-edge, policy-relevant research in health economics and (2) addressing the current changing health care reform environment by including sessions that focus on critical issues in the quality, coverage and access to health care that are of current importance for public policy and AHRQ.!

Public health relevance
Project Narrative The Annual Health Economics Conference brings together the leaders in the field of Health Economics to discuss and to present on issues that have a direct effect on public health policy in the US. The 28th Annual Health Economics conference will build upon the rich tradition established by the preceding twenty-seven Annual Health Economics Conferences of providing guidance to promising young researchers and feedback to important ongoing health economics and health services research.!